Reliability and Validity of Dynamic and Processing-based Assessments for Language in Diverse Bilingual School-age Children

Project Summary/Abstract
Children with developmental language disorder (DLD) demonstrate deficits in language compared to
unaffected peers from similar language-learning environments. Conventional assessment methods for DLD
capture a child’s current skill level in one language; in the U.S., such assessments are available only in English
or Spanish. These methods fail sequential bilingual children, who speak a minority language at home and are
subsequently exposed to English, because they confound language-learning ability with prior language-
learning experience. Assessments that index language-learning ability are sorely needed, especially for
sequential bilingual children whose home language is not Spanish. This project evaluates two novel approaches
to language assessment for sequential bilingual children: dynamic assessment and processing-based
assessment. Dynamic assessment methods offer language teaching during the assessment and evaluate the
child’s response. Processing-based methods assess underlying skills that may drive language learning. This
project rigorously examines the psychometric properties of dynamic and processing-based assessments within
a diverse group of sequential bilingual children entering English-based schooling. We will recruit 165 children
aged 4 years, 10 months to 6 years, 2 months who speak any non-English language at home. The first study
timepoint will occur as children enter the school year and include an experimental assessment battery with
dynamic assessments at the narrative and morpheme levels and both linguistic and non-linguistic processing-
based assessments. The assessment battery will be repeated 1 month later. Aim 1 establishes psychometric
properties of the experimental assessment battery, including internal consistency and test-retest reliability,
factor structure, and concurrent validity. Aims 2 and 3 then use a longitudinal design to examine predictive
validity. Children will be followed over two academic years, with re-assessment every 4 months (totaling 5
growth timepoints following the initial assessment and test-retest timepoint). At each growth timepoint,
children will complete an English language sample and parents and teachers will be interviewed to assess the
language environment and presence of concerns regarding the child’s language. We will construct models of
English growth that account for child-external factors (e.g., language environment, SES) and then determine
how well the experimental dynamic and processing-based assessment battery predicts this growth (Aim 2). We
will then identify a group of children at high risk of DLD based on the combination of poor English growth and
parent or teacher concern regarding language development. Aim 3 will examine the sensitivity and specificity
of the initial assessment battery for predicting DLD. Project results will demonstrate whether multiple dynamic
assessment and processing-based assessment tools can reliably and validly measure language-learning ability
across variable language-learning environments. For millions of children who speak home languages other
than English, this project represents a critical step in validating language assessment tools.

Public health relevance
Project Narrative (Public relevance statement) This project addresses the need to improve identification of developmental language disorders in children who speak a language other than English at home. We will investigate two novel approaches to language assessment that both aim to measure a child’s underlying language- learning ability. By rigorously evaluating these assessment approaches, including how well they predict English language growth over time and how well they index risk for language disorder, we will advance clinical and theoretical knowledge of language assessment with minority language learners (i.e., those who speak languages such as Spanish, Somali, Hmong, or Karen).